Nutrient Sensing of Apoptotic Cells by Macrophages Resolves Inflammation, Drives Atherosclerosis Regression, and Promotes Features of Plaque Instability

PROJECT SUMMARY/ABSTRACT
Atherosclerotic cardiovascular disease (ASCVD) remains the leading cause of morbidity and mortality worldwide.
While most atherosclerotic plaques remain clinically asymptomatic, a subset lead to myocardial infarction, stroke,
or sudden death. These unstable atheromas feature a large necrotic core, primarily resulting from defective
efferocytosis – a failure in the receptor-mediated process by which macrophages recognize, engulf, and degrade
apoptotic cells (ACs). When efferocytosis fails, ACs become necrotic and generate a robust inflammatory
response that drives atherosclerosis progression. Notably, the successive uptake of multiple ACs by individual
macrophages, termed “continual efferocytosis”, is essential for inflammation resolution. However, this becomes
increasingly compromised as atherosclerosis advances. Because the mechanisms underlying continual
efferocytosis remain poorly understood, we aim to define the underpinnings driving the successive clearance of
ACs by macrophages, revealing new therapeutic approaches to stabilize rupture-prone atheromas. Our
supporting data provided herein indicate that nutrient-sensing of AC-derived cargo is a critical checkpoint that
enables macrophages to successively clear multiple ACs rapidly. We show that the mammalian target of
rapamycin complex 1 (mTORC1) is robustly activated in response to nutrient availability during efferocytosis,
and inhibition of mTORC1 significantly reduces continual efferocytosis. Additionally, we provide evidence that
the nutrient sensor SLC38A9 activates mTORC1 after AC uptake, drives phagolysosomal fission, and promotes
continual efferocytosis. Mice lacking myeloid SLC38A9 (Slc38a9fl/fl Lyz2Cre+/-) exhibit defects in continual
efferocytosis and increase necrosis in the dexamethasone-induced thymus injury model compared to controls
(Slc38a9fl/fl). Notably, SLC38A9 expression is significantly reduced in lesional macrophages within unstable
human atheromas and advanced plaques in mice, driven by TNFα- and IL-1β-mediated repression. Furthermore,
unbiased transcriptomics comparing control and SLC38A9-deficient macrophages reveal significant differences
in pathways associated with membrane trafficking, efferocytosis, and atherosclerosis. These data support our
central hypothesis that SLC38A9-mediated nutrient sensing of AC-derived cargo activates the phagocytic
machinery required for continual efferocytosis and drives inflammation resolution. We will address this
hypothesis by pursuing the following aims: (1) to define the mechanisms by which SLC38A9-mediated mTORC1
activation promotes phagolysosomal fission, membrane trafficking, and continual efferocytosis; and (2) to
elucidate the mechanisms through which SLC38A9 drives inflammation resolution, stimulates atherosclerosis
regression, and promotes features of plaque stability. Successful completion of this proposal will provide new
mechanistic insights into the role of nutrient sensing in efferocytosis and identify novel therapeutic strategies to
stabilize rupture-prone atheromas.

Public health relevance
PROJECT NARRATIVE While most atherosclerotic plaques remain clinically asymptomatic, a subset can lead to myocardial infarction and sudden death, primarily due to an impairment in the successive clearance of apoptotic cells (ACs) by macrophages, termed “continual efferocytosis”. Our research has identified a previously unrecognized metabolic checkpoint involving nutrient sensing of AC-derived cargo in the phagolysosome by the arginine and cholesterol sensor SLC38A9. Because the mechanisms underlying continual efferocytosis are poorly understood, we aim to uncover the processes driving successive AC clearance, revealing new therapeutic approaches to stabilize rupture-prone atheromas.